Elucidating the Sexual Cycle of HIV/AIDS-Related Pneumocystis Pneumonia

Pneumocystis jirovecii is a fungal pathogen that causes pneumonia (PjP) in immunocompromised patients.
Trimethoprim-sulfamethoxazole (TMP-SMX) is the first line drug for the treatment and prophylaxis of PjP.
However, many patients cannot tolerate TMP-SMX due to severe allergic reactions. Secondary treatments such
as pentamidine are either toxic or not as effective as TMP-SMX. PjP remains refractory to most common
antifungal drugs necessitating novel approaches for new agent discovery. Echinocandins are anti-fungal drugs
that target the synthesis of β -1,3 -D-glucan (BG), found in fungal cell walls. Treatment with echinocandins in
rodent models of PjP resulted in disappearance of asci and inability to transmit infection. Bulk RNA-Seq studies
of anidulafungin treated mice showed an apparent dysregulation in mating type receptor expression and other
genes associated with sexual reproduction in addition to BG inhibition. These findings led to the concept that
Pneumocystis spp. are obligated to undergo sexual reproduction to survive. We showed that 8 weeks of
treatment with the echinocandins, rezafungin and anidulafungin, could eradicate the pneumonia in mice. Since
there was no “salvage” asexual replication, this finding provides further evidence that these fungi must sexually
replicate to survive and that the sexual cycle presents a novel drug target. Based on the critical role of asci
production via the sexual process we propose to define the sexual cycle of these fungi, then use the defined
sexual stages to identify potential drug targets that could be used in combination therapy with echinocandins to
eradicate/prevent the infection. As a test of concept, we will evaluate antibody-directed therapy to the mating
receptor proteins as the initiators of the sexual cycle, alone and in combination with anidulafungin. Our aims are
to: Aim 1. Define the stages of the sexual cycle of Pneumocystis species using single cell profiling
(scRNA-seq). Two surrogate rat models, corticosteroid immunosuppressed and CD4+ depletion, will be used
to define the sexual cycle and determine whether the host immune milieu might affect the life cycle. Male and
female sources of P. carinii will identify any sex-related variances. We will then determine whether the life cycle
of P. jirovecii corresponds to that of P. carinii. Aim 2. Identify reconstituted sexual cycle genes after release
from anidulafungin treatment. T h e goal of this aim will be to identify the genes temporally expressed during
reconstitution of the sexual cycle after anidulafungin treatment as a strategy to prioritize potential drug
targets. Along with the scRNA-seq, fluorescent microscopy using the antibodies to the mating receptors, the
anti-BG mAb, and DAPI staining will reveal the kinetics of repopulation of the sexual life cycle stages.
Aim 3. Treatment with antibodies to Mam2p and Map3p of P. carinii with and without anidulafungin: a
test-of-concept study. We posit that identification of genes upstream of the BG target, will provide candidate
drug targets that will act in synergy with anidulafungin to eradicate the infection. As a test of concept for
combination therapy, we will treat PjP in the rat model with antibodies to Mam2p andMap3p and anidulafungin.

Public health relevance
Project narrative. Pneumocystis jirovecii pneumonia (PjP) is the most common opportunistic infection in persons with HIV. Development of new approaches for therapy and prophylaxis of PjP are critically needed due to the very limited armamentarium available. The echinocandins halt the ability of these fungi to proceed through sexual replication. Using single cell RNA-Seq, a rigorous validation pipeline, and in vivo proof- of - concept, we propose to identify additional drug targets in the sexual cycle with the goal of reducing treatment time and efficacy with a combination of agents.